Project 1: Development of an HTLV-1 mRNA vaccine

PROJECT SUMMARY/ABSTRACT - PROJECT 1: Development of an HTLV-1 mRNA vaccine
The study of retroviruses has led to important discoveries in basic cell biology including cell signaling, regulation
of gene expression, cellular transformation, and cancer development. Our collaborative work within this P01
focuses on human T-cell leukemia virus type 1 (HTLV-1), which is the infectious cause of adult T-cell
leukemia/lymphoma (ATLL) and the neurodegenerative disease HAM/TSP. Disease progression by HTLV-1 has
been attributed to the viral gene Tax. However, we and others have provided strong evidence that another viral
gene, termed Hbz, plays a critical role throughout infection, establishment of latency, and finally in the malignant
process. In the past funding cycle, we identified the importance of Hbz in HTLV-1 pathobiology through gene
editing (Viral Vector Core). These results support the utility of future Hbz-targeted therapeutic mechanisms for
the treatment of HTLV-1-associated diseases. We also expanded our proposed work through P01 collaborations
to develop an envelope (Env) mRNA lipid nanoparticle (LNP) vaccine (Project 3, Animal Core). mRNA vaccine
technology has recently emerged as a safe, effective, and scalable approach to combat infectious diseases and
cancer, offering several advantages over traditional vaccine design and production. The HTLV-1 Env
glycoprotein is immunogenic and required for entry of target cells – making it a favorable target for vaccine
development. Our initial Env mRNA-LNP vaccine candidate is immunogenic and protective in our rabbit model
of infection. However, a majority of ATLL patients do not express Env (or Tax), whereas Hbz is the only viral
gene consistently expressed throughout infection and disease development. Taken together, this suggests that
an effective vaccine against HTLV-1 and subsequent disease development should target both Hbz and Env. Our
overall hypothesis is that an HTLV-1 mRNA-LNP vaccine (Hbz, Env) can be developed to elicit neutralizing
antibody (nAb) and T-cell responses that prevent infection and/or HTLV-1-mediated disease. This highly
integrated proposal has three Aims and several Project and Core collaborations. Aim 1 will identify the optimal
immunogenic Hbz and Env mRNA vaccine using different vaccine candidates. We will utilize in vitro approaches
to examine relative efficacy (expression, localization, conformation, effects on cell signaling) of each vaccine
candidate. We will also use in vivo approaches to assess and compare vaccine immunogenicity (Ab, nAb, T-cell
responses) in HLA-transgenic mice (Project 3, Animal Core B). Aim 2 will measure the effectiveness of Hbz
and/or Env mRNA vaccine protection. Studies in rabbits will measure vaccine-induced Ab, nAb, T-cell responses,
protection against viral challenge, and treatment of viral infection (Project 3, Animal Core B, Genomics Core
C). Studies in HLA-transgenic humanized mice will be used to measure vaccine protection against and treatment
of disease (Project 2, Animal Core B, Genomics Core C). We will also characterize genomic phenotype of
cells that escape vaccine protection (Genomics Core C). Aim 3 will assess the importance of nAb and/or CD8
T cells on protection and vaccine response in animals (Animal Core B, Genomics Core C).

Public health relevance
PROJECT NARRATIVE – PROJECT 1 Adult T-cell leukemia/lymphoma (ATLL) is an aggressive, non-Hodgkin’s lymphoma caused by the oncogenic retrovirus human T-cell leukemia virus type 1 (HTLV-1) – for which no widely available curative therapy exists. This proposal will design and develop HTLV-1 mRNA lipid nanoparticle vaccine candidates against viral Hbz and Env that elicit neutralizing antibody and cytotoxic T-lymphocyte responses which prevent and/or treat the formation of HTLV-1 preneoplastic cells and disease. Studies of the efficacy and nature of the immune response to this vaccine will elucidate determinants of immune protection against HTLV-1 infection and HTLV-1 disease development.